Pathology support for the toxicological evaluation of Aspergillus versicolor inhalation in mice

This study supports the NTP and our interagency partnership with NIOSH by providing pathology support (including necropsy and histopathology) for a 3-month inhalation exposure study of mice exposed to Aspergillus versicolor.